SERVICES FOR A SUPPLEMENT TO THE JOURNAL OF THE NATIONAL CANCER INSTITUTE (JNCI), IN SUPPORT OF THE DEPARTMENT OF HEALTH AND HUMAN SERVICES, NATIONAL INSTITUTES OF HEALTH (NIH), NATIONAL CANCER INSTIT

SERVICES FOR A SUPPLEMENT TO THE JOURNAL OF THE NATIONAL CANCER INSTITUTE (JNCI), IN SUPPORT OF THE DEPARTMENT OF HEALTH AND HUMAN SERVICES, NATIONAL INSTITUTES OF HEALTH (NIH), NATIONAL CANCER INSTITUTE